A Novel Approach to Enhance Therapeutic Efficacy of Tarlatamab for Small Cell Lung Cancer Treatment

PROJECT SUMMARY
Small cell lung cancer (SCLC) is a highly aggressive form of lung cancer with a dismal survival rate. The response
of SCLC to current therapies is short-lived and the disease progression is inevitable in most patients.
Furthermore, unlike other lung cancer types, there is a notable scarcity of targeted therapies in SCLC. The
bispecific T-cell engager (BiTE) antibodies represent a transformative new approach in cancer therapy that
facilitates T-cell-mediated eradication of cancer cells. Due to their effectiveness the U.S. FDA has approved
several BiTE antibodies for treating various cancers. Delta-like ligand 3 (DLL3) is overexpressed in most SCLCs,
which prompted the development of a novel BiTE antibody, Tarlatamab. Tarlatamab specifically targets DLL3
on SCLC cells and CD3 on T-cells, leading to T-cell mediated tumor lysis. In the recent Phase II clinical trial
DeLLphi-301, Tarlatamab demonstrated potent anti-tumor activity, achieving durable objective responses in 40%
of previously treated SCLC patients and showing encouraging survival outcomes. The Phase III clinical trial
(ClinicalTrial.Gov ID# NCT05740566) is underway and its clinical approval in the third-line (3L) setting for SCLC
is expected to occur this year. However, the median progression-free survival benefit with Tarlatamab is limited
to approximately 4.9 months, highlighting the need to identify molecular drivers of response, which will allow
more effective use of Tarlatamab in SCLC patients. We performed a CRISPR-based gene activation (CRISPR-
a) screen by activating the expression of over 350 human genes encoding epigenetic regulators. This screen
and subsequent analyses identified EZH2 overexpression as a key event that drives Tarlatamab resistance in
SCLC. Our overall objective is to determine the in vivo role of EZH2 in conferring resistance to Tarlatamab in
SCLC and evaluate pharmacological inhibition of EZH2 for enhancing the efficacy of Tarlatamab in SCLC. In
Aim 1 studies, we will model the in vivo impact of genetic and pharmacological inhibition of EZH2 in forestalling
and reversing the resistance to Tarlatamab in SCLC. To test this, we will use human SCLC cells and T-cell
admixture mouse model and a novel immunocompetent humanized mouse model with a human immune system.
To pharmacologically inhibit EZH2, we will use a U.S. FDA approved EZH2 inhibitor Tazemetostat, and test if
treatment of SCLC cells with Tazemetostat can forestall and/or reverse the resistance to Tarlatamab in SCLC.
In Aim 2 studies, we will elucidate the role of canonical and non-canonical functions of EZH2 in driving resistance
to Tarlatamab in SCLC. First, we will determine the role of EZH2-mediated transcriptional repression of DLL3
and other DLL3-independent mechanisms in conferring resistance to Tarlatamab. Next, we will utilize the EZH2
degrader, MS1943, and a catalytically inactive mutant of EZH2 to probe the non-canonical functions of EZH2 in
determining resistance to Tarlatamab in SCLC. Collectively, these studies will identify a novel therapeutically
targetable pathway to enhance the efficacy of Tarlatamab in SCLC.

Public health relevance
PUBLIC HEALTH SIGNIFICANCE Small cell lung cancer (SCLC) is a highly aggressive subtype of lung cancer characterized by rapid growth and early metastasis to multiple distal organs and it poses significant clinical challenges due to the limited efficacy of existing treatments, high relapse rate, and a notable scarcity of targeted therapies. Tarlatamab, a bispecific T- cell engager (BiTE) antibody, has demonstrated clinical efficacy in treating SCLC, based on these findings, we performed studies to identify factors that determine the response to Tarlatamab in SCLC, which led to the identification of EZH2 as a major chromatin modifier that confers resistance to Tarlatamab. Our studies will determine the role of EZH2 in driving resistance to Tarlatamab and establish the efficacy of a Tarlatamab and EZH2 inhibitor combination therapy as a more effective strategy for treating SCLC than using Tarlatamab alone.